Deciphering fungal pathogen-specific cell cycle mechanisms to fuel drug discovery

Project Summary
Fungal infections are a pressing and underappreciated threat to global public health, causing an estimated 2.5
million deaths each year. One major contributing agent is Cryptococcus neoformans, a globally distributed
opportunistic fungal pathogen capable of causing life-threatening meningitis in immunocompromised individuals.
Available treatment options for cryptococcal infections and fungal infections in general are limited, underscoring
the urgent need for new antifungal development. Two main challenges in combating fungal pathogens are the
cellular similarities between fungi and human hosts and their abilities to evade the host immune system. In the
case of C. neoformans, the typical small haploid yeast cells undergo a striking morphological transition to form
giant, highly polyploid “titan cells” to escape phagocytosis by host immune cells. A key to C. neoformans’s ability
to proliferate and form titan cells in the host is the cell cycle machinery. Despite being essential for pathogen
proliferation and pathogenicity, the cell cycle machinery has been traditionally excluded as a target for antifungal
drug development due to its high conservation between fungi and humans. However, there are differences and
modifications in the cell cycle program that are fungal-specific or unique to C. neoformans. Here, I propose to
exploit these cell cycle variations essential for fungal proliferation or immune evasion for antifungal drug
development. To realize this vision, I have identified two promising cell cycle variations to investigate in C.
neoformans. Aim 1 will focus on a fungal-specific cell cycle pathway known as the mitotic exit network (MEN).
The MEN is highly conserved in fungi and functions in a fungal-specific cell cycle checkpoint in the budding yeast
Saccharomyces cerevisiae, thus providing a potential target for broad-spectrum antifungals. This proposal will
determine the function and signaling mechanisms for the MEN in C. neoformans. In addition, we will develop a
strategy to perform high throughput genetic interaction mapping using CRISPR/Cas9-mediated gene editing and
an inducible degron system to dissect the regulatory network surrounding the MEN in C. neoformans. The goal
of
Aim 2 is to pinpoint the specific cell cycle alterations that program the reversible titan cell formation. In addition
to promoting immune evasion via polyploidization, the titan cells undergo an unusual reductive division to
produce haploid daughters to facilitate dissemination to distant tissues such as the brain. We will systematically
track and perturb cell cycle progression during titan cell formation and division to distinguish potential models for
the polyploidization and reductive division. In parallel, we will perform high throughput phenotyping with a
genome-wide depletion library to identify key regulators for the cell cycle alternations in both processes. The
proposed study will help identify new drug targets for the important human fungal pathogen C. neoformans and
provide a proof of principle for the unconventional and generalizable approach of targeting the cell cycle for
antifungal drug development.

Public health relevance
Project Narrative Fungal infections are a pressing and underappreciated threat to global public health, yet treatment options are limited due to the cellular similarities between fungi and humans. Using an important human fungal pathogen Cryptococcus neoformans as a model system, this proposal aims to dissect fungal-specific cell cycle variations that are essential for C. neoformans’s ability to proliferate and evade the host immune system during infection. Results from this work will uncover unique aspects of fungal pathogen biology and facilitate the identification of new targets for antifungal development.